Phagocyte Crosstalk in the Balance of Inflammation & Cardiac Disease

Thorp Project Summary Abstract
Acute ischemic injury and heart failure (HF) are significant causes of morbidity and mortality that
lack effective therapeutic strategies. Though diverse in their etiology, a common and critical
contributor to their disease pathophysiology is the chronically activated macrophage phagocyte.
As such, the resolution of cardiac inflammation through selective dampening of macrophge
hyperactivity and the promotion of inflammation resolution, has the potential to ameliorate
pathophysiology and improve heart health. In the case of HF, which has been earmarked as a
research priority by the National Institutes of Health, risk factors such as high fat and
hypertension are commonly present and directly contribute to chronic inflammation. During
cardiac injuruy and HF, the extent of inflammation and inflammatory macrophages in the
myocardium has been linked to the degree of cardiac fibrosis and myocardial stress, and this
likely contributes to impaired cardiac performance. However, underlying causal mechanisms
and immune molecular protagonists remain incomplete. A similar lack of understanding pertains
to how innate inflammation contributes to crosstalk with other cells found in the heart, including
cardiac lymphatics. In this setting, cell subsets and molecular factors that regulate inflammation
resolution and tissue repair remain unclear. Taken together, our studies will focus on and
identify key and maladaptive immunometabolic signaling pathways specific to cardiac disease.
In the case of heart failure, we will examine on how risk factors synergize to rewire macrophage
signaling circuits that fuel chronic cardiac inflammation. We will also elucidate new pathways by
which macrophages communicate with progenitor cells, the underlying molecular mechanisms,
and the potential of therapeutic amelioration. Our overall objectives leverage newly generated
and cutting-edge experimental tools through approaches in experimental animals and humans.
These studies will combine improved basic understanding of novel and disease-specific cellular
mechanisms with the identification of new therapeutic candidates for heart failure, inflammation
resolution, and tissue inury.

Public health relevance
Thorp Narrative Lay Unresolved inflammation of the heart encompasses a diverse array of pathologies, including acute ischemia and cardiometabolic associated heart failure. Common to these pathologies is activation of myeloid cell subsets, which due to their functional plasticity, have the capacity to either promote or resolve inflammation through intercellular crosstalk. This proposal will identify novel intercellular and metabolic regulatory pathways in and between myeloid phagocytes and their progenitor cells that causally modify cardiac inflammation in experimental animals and associated human and therapeutic relevance.